A Novel Physiologically Based Pharmacokinetic (PBPK) Modeling Approach to Facilitate Safer Medications During Lactation

Summary/Abstract
Drug transfer into breast milk has consistently been a safety concern for medication use in breastfeeding
women. Studies have shown that women use an average of three different medicines during lactation.
Knowing how much of a drug is secreted into breast milk is critical for ensuring the safe use of medications for
lactating mothers. Carrier-mediated transport plays a crucial role in drug transfer into human milk, particularly
through efflux transporters that actively transport their substrates into breast milk. However, many challenges
remain on obtaining accurate information of drug transfer into breast milk. Our research endeavors in this area
have made significant progress, including the development of a new in vitro to in vivo extrapolation (IVIVE)
approach to predict milk-to-plasma ratios (M/P), a human normal mammary epithelial cell-based permeability
assay, and a mechanistic physiologically based pharmacokinetic (PBPK) modeling approach incorporating
breast cancer resistance protein (BCRP) transporter to predict drug pharmacokinetics in the milk. These
findings demonstrate that better prediction of milk-to-plasma (M/P) ratio needs a systemic approach that
contains reliable in vitro assays to generate extrapolable drug parameters and a robust IVIVE approach like
PBPK modeling that can integrate physiology and drug characteristic to run proactive predictions for general
population and design precision dosage regimens for certain populations. Therefore, we hypothesize that a
systemic and generalized IVIVE and PBPK modeling approach will highly improve prediction accuracy of drug
transfer into breast milk. Since efflux drug transporters present on mammary epithelium have a significant role
on drug transfer into breastmilk and there is a huge knowledge gap of their role, two P-glycoprotein (P-gp) drug
substrates (clarithromycin and digoxin), four BCRP drug substrates (bupropion, cimetidine, ciprofloxacin and
nitrofurantoin), and three passive diffusion drugs (atenolol, metoprolol and tramadol) will be used as probe
drugs for this project. We will develop a novel lactating-like mammary epithelium barrier from human induced
pluripotent stem cells (hiPSCs) to determine drug transfer in vitro and determine the fraction unbound of drugs
in the plasma and breast milk. We will isolate human mammary epithelial cells (hMECs) from human breast
milk and stimulate MECs from human reduction mammoplasty to be lactocyte-like cells. These cells will be
used for running a stable heavy isotope-labeled full-length protein internal standard (IS)-based targeted
proteomics assay to quantify the absolute drug transporter expression for IVIVC. Finally, a mechanistic
lactation PBPK models will be developed by incorporating in vitro parameters, scaling factors, physiological
and drug parameters. This research will have a significant impact to support safer medication use during
lactation and develop precision therapeutics during lactation.

Public health relevance
Project Narrative This project aims to develop a novel approach for accurately predicting the transfer of medications into breast milk during lactation. By addressing the current knowledge gap and providing a reliable predictive method, this research will significantly enhance our understanding of medication secretion into breast milk. The outcomes will play a crucial role in promoting safer medication use during lactation and advancing the development of precision therapeutics tailored for lactating mothers.